In Vivo Neuroprotective Properties and Action Mechanism(s) of Plant-produced Asialo-erythropoietin

Abstract
There is an acute need to develop neuroprotective drugs to prevent or/and protect neuronal cell
damage and death caused by ischemia/reperfusion, hypoxia or cytotoxic agents in the brain. Plant-
based expression system can be used to produce asialo-rhuEPO, a non-hematopoietic
recombinant human EPO derivative lacking sialic acid, which could be used as a neuroprotective
agent for preventing and protecting brain damage from ischemia/reperfusion injury. In our previous
studies, we found that plant-produced asialo-rhuEPO (asialo-rhuEPOP) is non-erythropoietic and
displays excellent neuroprotective effects in a young mouse model of middle cerebral artery
occlusion (MCAO) I/R injury. Our previous studies have set the stage for the current proposed
research activities. In this SC1 renewal application, we propose to extend asialo-rhuEPOP-mediated
neuroprotection studies to aged mice, evaluate long-term neurological outcomes in both young and
aged mice, and further understand its neuroprotective mechanisms.

Public health relevance
Project Narrative There is an acute need to develop neuroprotective drugs to prevent or/and protect neuronal cell damage and death caused by ischemia/reperfusion, hypoxia or cytotoxic agents in the brain. Plant- based expression system can be used to produce asialo-rhuEPO, a non-hematopoietic recombinant human EPO derivative lacking sialic acid, which could be used as a neuroprotective agent for preventing and protecting brain damage from ischemia/reperfusion injury.